The impact of brain lipoprotein structure and composition on amyloid beta metabolism and Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is a debilitating brain disorder characterized by memory loss and cognitive decline,
affecting millions worldwide. The intricate interplay between lipid metabolism and AD pathology is increasingly
recognized, and brain lipoproteins (BLps) are thought to be key players given they serve as the primary lipid
transport vehicles in the central nervous system (CNS). BLps reside in the cerebrospinal fluid (CSF) that bathes
the brain but unfortunately, due to their low abundance and limited accessibility, a comprehensive understanding
of BLps has remained elusive. We developed a fluorescent lipoprotein profiling (FLP) technology that hurdles
this abundance problem to deeply characterize BLps in small volumes of CSF. Using our FLP and mass
spectrometry (LC-MS/MS), we revealed that BLps consist of a spectrum of discretely sized subpopulations that
exhibit remarkable proteomic diversity. We posit that the dominant organizing scaffold on BLps, apolipoprotein
(APO)E, acts as a master regulator of BLp composition by adopting distinct structural conformations to facilitate
docking with complementary partners that impart unique functions. APOE has three isoforms—E2, E3, and E4
differentiated by cysteine-arginine mutations at residues 112 and 158 and carriers of APOE4 have increased
amyloid plaque burden, and substantially increased lifetime risk for developing AD. We hypothesize that
conformational differences between APOE isoforms alter BLp compositional signatures and their ability to bind
and traffic amyloid beta (Aβ), the building block of amyloid plaques. Our objectives are two-fold: First, to assess
the impact of APOE isoforms on BLp distribution, composition, and ability to bind Aβ. To do so, we will perform
a comparative analysis of BLp patterns in individuals with different APOE genotypes and levels of cognitive
health using our FLP and LC-MS/MS, shedding light on the AD-relevant BLp subspecies. Second, we aim to
unravel the structural details of lipid-bound APOE isoforms that govern their interactions with Aβ. Using cryo-EM
and novel structural proteomics approaches, we will derive high-resolution structural maps of Aβ complexed with
different APOE isoforms on reconstituted HDL and determine how “accessory” proteins found on BLps modulate
their interaction with Aβ. These studies will provide a detailed molecular map of BLp metabolism in the CNS
which can be leveraged for the development of targeted therapeutic approaches to treat and prevent AD.

Public health relevance
PROJECT NARRATIVE Brain lipoproteins are lipid-protein complexes produced in the central nervous system that are important for maintaining brain health. The primary protein component on these particles is apolipoprotein (APO)E which has three different forms in people: E2, E3, and E4 and people who have E4 are at an elevated risk for development of Alzheimer’s disease. This work is aimed at understanding how E4 impacts the ability of brain lipoproteins to protect against the development of Alzheimer’s disease.